Equipment Supplement: Understanding the Cellular Basis of Movement Disorders

Project Summary
Spinocerebellar ataxia type 1 (SCA1) is an autosomal dominant neurodegenerative disease caused by a CAG
trinucleotide repeat expansion in ATXN1 that leads to an abnormally long polyglutamine tract in the
subsequent protein, ataxin-1 (ATXN1). Mutant ATXN1 has a propensity to misfold, resist cellular degradation,
and increase in toxicity as its levels rise. This toxicity occurs by a gain of function mechanism with evidence
point to transcriptional derangements as an early, presymptomatic pathogenic event. We recently discovered
that the earliest abnormalities in Purkinje cells (cells that are most vulnerable in SCA1) are not caused by cell-
autonomous changes but in a non-cell autonomous manner by affecting the proliferation and fate of cerebellar
post-natal stem cells. In this proposal, we will test the hypothesis that the underlying SCA1 pathology has its
roots in early developmental processes and that if these defects are overcome one might be able to delay or
ameliorate later neurodegeneration, thus paving the way for therapy for this currently untreatable condition.

Public health relevance
Spinocerebellar ataxia type 1 (SCA1) is an autosomal dominant neurodegenerative disease caused by a CAG trinucleotide repeat expansion in ATXN1, thus leading to a misfolded, degradation resistant, toxic mutant protein. We discovered that early cerebellar developmental abnormalities in SCA1 occur in a non-autonomous manner. In this proposal we seek to elucidate the consequences of these early developmental changes and whether thwarting these abnormalities can ameliorate disease progression. Ultimately helping us to understand the pathological basis of SCA1 and identifying possible therapeutic targets.